Developmental and Neonatal Biology Training Program

[unreadable] DESCRIPTION (provided by applicant): The prime objective of the Training Program in Developmental and Neonatal Biology is the education and training of basic researchers and clinician investigators for academic careers in the developmental sciences and neonatology. The Program is designed to encourage the cross-fertilization of ideas that will enrich the research of both the basic- and the clinically oriented scientist. For those trainees interested in the basic sciences, the Program offers exposure to clinical problems that stimulate curiosity in human development and enhance the translation of bench research between investigators in basic science departments and physicians in clinical departments, sharing as a common goal an in-depth understanding of the development of organ systems. For those trainees interested in clinical training, the Program offers intensive clinical experiences with newborns, including the opportunity for clinical investigation, as well as advanced study in developmental biology, especially at the cellular and molecular level. Predoctoral trainees enter a flexible predoctoral program where they select their preceptors and receive their degrees from one of the eight Ph.D. granting academic units (the Departments of Biological Sciences, Developmental Biology, Genetics, Molecular and Cellular Physiology, Molecular Pharmacology, Microbiology and Immunology, Structural Biology, and Neurobiology) as well as from the Combined Admissions Mode in the Medical School. Trainees for this component of the Program are selected by the Predoctoral Committee. Postdoctoral trainees have completed a Ph.D., M.D., or equivalent degree and are nominated by a preceptor following a formal application procedure. Candidates for support are evaluated by the Postdoctoral Committee. Postresidency trainees have completed residency training in General Pediatrics and possess the knowledge and skills of a Board-certified general pediatrician. These trainees, therefore, assume increasing clinical responsibilities in the care of critically ill premature and full term neonates. All trainees interact with each other and with preceptors within a program to represent a wide range of interests in developmental biology, from the most basic to the applied sciences, which enhances the breadth and depth of the training experience. [unreadable] [unreadable]